FOOD SAFETY ISSUES TO ENABLE ASEPTIC PROCESSING OF MULTIPHASE FOODS

MRI allows the measurement of processing temperatures in multiphase (macroscopic solid and liquid components) foods. This information is essential in testing the efficacy of heating during aseptic processing.